Optoelectroactive citrate biocomposites for bone regeneration

Project Summary
Bone regenerative biomaterials are of critical importance in treatment of bone defect, enhanced bone healing,
reduction of pain and disability, replacement of damaged or diseased bone, and development of new
orthopedic treatment options among others. With many years of endeavors, the field of orthopedic regenerative
biomaterials has seen tremendous progress, but many challenges remain. For instance, the currently available
bone regenerative biomaterials are featured with inabilities to mimic the native tissue composition, and slow
bone regeneration among others. The goals of this proposal are to elucidate an unexplored synergistic
optoelectrostimulation and metabonegenic regulation for bone development, and to translate these
understandings towards the design of novel biomimetic optoelectroactive citrate-presenting bone biomaterials
for orthopedic applications for promoted bone repair. The proposed optoelectroactive citrate biocomposites
(OCBs) that will enable synergistic osteopromotive effects between exogenous citrate supplement and in situ
electrostimulation by wireless untethered photo-illumination to provide increased cellular energy supply in
osteodifferentiated stem cells, as referred to a novel strategy of optoelectro-metabonegenic regulation. The
OCBs will allow for citrate release in a control rate and in situ optoelectrostimulation through µ-solar cell
pellets, where the µ-solar cell pellets will also be designed to be biodegradable to match the time frame of
bone regeneration.

Public health relevance
Project Narrative Existing bone regenerative biomaterials are featured with inabilities to mimic the native tissue composition, and slow bone regeneration among others. In this proposal, we will reach a fundamental understanding of unprecedented synergistic optoelectro-metabonegenic regulation mechanism in bone repair, will design biomimetic optoelectroactive citrate biocomposites to achieve promoted bone repair. Our study will hold the potential to transform the fields of issue engineering and regeneration, and bioelectronics among others.